Coordination of M1 projection neuron subtypes by oscillations

PROJECT SUMMARY/ABSTRACT
Motor acts such as reaching often rely upon the primary motor cortex (M1) for their execution. Oscillatory
activities in M1 accompany motor actions, with the dominant electroencephalographic correlate of those actions
being event-related desynchronization (ERD), a loss of low frequency power during movement onsets.
Intracerebral recordings in humans, monkeys, and rodents have found that ERD co-occurs with movement
associated gamma oscillations in M1. Gamma has received increased attention as a therapeutic target because
it is altered in several movement disorders and affected by transcranial stimulation. However, the microcircuitry
and function of gamma oscillations in M1 are not well studied. Given the abundance of specialized projection
neurons in M1, it is crucial to understand how they are coordinated by gamma in normal subjects. In other cortical
circuits, gamma oscillations depend on the interaction between principal cells (PNs) and fast-spiking
interneurons (FSIs). In M1, projection-specific PN subtypes differ in their connectivity with FSIs, suggesting that
they are differentially regulated by gamma. This project seeks to understand how gamma oscillations during
reaching orchestrate three major classes of PNs in M1: pyramidal tract, corticostriatal, and corticothalamic. In
Aim 1, local field potentials and single unit activity in M1 are recorded during a skilled reaching task in rats.
Extracellular spike waveform characteristics will be used to identify FSIs, while PNs will be classified with
antidromic stimulation. Paw kinematics will be tracked to measure reaching. For each PN subtype, we will
characterize entrainment to gamma, coordination with FSIs, and reaching correlates. Aim 2 dissects the circuit
mechanisms underlying any projection-specific differences in gamma entrainment. For each pair of PN subtypes,
one will be made to selectively express the excitatory opsin ChroME, while the other will be labeled with GFP.
In M1 brain slices, whole-cell patch clamp recordings will be made from both populations during gamma induced
by optogenetic ramp stimuli. This will reveal the ability for the opsin-bearing population to induce local gamma,
and how sensitive the GFP population is to it. Voltage clamp recordings will reveal the relative contributions of
EPSCs and IPSCs to these rhythms, further illuminating circuit mechanisms. Lastly, Aim 3 assesses the
behavioral importance of gamma entrainment. During the reaching task closed-loop optogenetic modulation of
each of the PN subtypes will be delivered to bias their spiking either in- or out-of-phase with ongoing M1 gamma.
The effect this has on gamma amplitude, behavioral performance, and the unstimulated projection PNs, will be
determined. Altogether, these aims offer a comprehensive characterization of how M1 gamma coordinates the
output microcircuitry, clarifies its physiology, and tests its behavioral relevance. Those insights are necessary for
deepening our understanding of oscillatory activities in M1 and motor disordes, and perfecting future therapies.

Public health relevance
PROJECT NARRATIVE Gamma oscillations are produced in the primary motor cortex during reaching or exploratory movements and disrupted by disease. This proposal uncovers how gamma oscillations coordinate neurons in primary motor cortex and determines their behavioral relevance. Understanding this is important for interpreting their dysfunction in clinical populations and devising better therapies.